Research Resources and Workforce Development for the Rocky Mountain Regional Biocontainment Laboratory at Colorado State University

Project Summary: The Rocky Mountain Regional Biocontainment Laboratory (RMRBL) at Colorado State
University (CSU) has been responsive to the national RBL mission to: 1) “Conduct research on biodefense and
emerging infectious disease agents”; 2) “Be available and prepared to assist national, state, and local public
health efforts in the event of a bioterrorism or infectious disease emergency” since its opening and full
commissioning in 2008. Researchers at the RMRBL and their collaborators rapidly pivoted in response to the
emergence of Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2), working on host-derived
therapeutics, vaccines, and identifying other potential zoonotic reservoirs as spillover opportunities in wildlife
and domestic animals. Our researchers similarly pivoted this past year to work on countermeasures in
response to the re-emergence of Mpox, while also continuing to address high consequence pathogens that
have chronically plagued public health systems, such as Mycobacterium tuberculosis, the causative agent of
Tuberculosis. Beyond our demonstrated ability to rapidly address research and research service needs on
pathogens with pandemic potential, our team contributes to training, outreach, and access of our facility via
sponsored fellowships, visiting scholars’ programs, workshops, conferences, and through collaborations.
Despite these gains, our RMRBL BSL3 suites are aged, requiring constant investments to maintain safe,
secure and compliant BSL3 facilities. RMRBL BSL3 researchers, support staff, and biosafety professionals are
vulnerable to the strain of the work environment, limited resources, funding gaps, and opportunities to engage
in less risky fields equipped with cutting edge technologies. In this application, we respond to the challenges
facing the RMRBL BSL3 laboratories with 3 Cores. Core 1 includes an improved management structure,
systematic replacement of deprecating scientific instruments, and comprehensive and proactive maintenance
of existing facilities needs to ensure compliance and continuous functioning. Operation of the RMRBL BSL3 is
additionally enhanced to improve the working environment and increase consistency for operations research
support and animal husbandry staff. Core 2’s initiatives seek to develop training programs responsive to adult
learning and education best practices, ensuring improved safety and safety compliance in persons working in
the BSL3. Biosecurity upgrades will improve the safety and security climate in anticipation of new national
standards, and integration between research teams and the office of Biosafety in constructing and training in
technical standard operating procedures will accelerate safe performance and technical competence. Finally,
Core 3 synthesizes our research strengths to develop a uniquely qualified Biocontainment Research
Resources Core, bringing together opportunities to exploit team talent and perform innovative research.
Combined, our three Cores ensure that the RMRBL BSL3 facilities are always ‘warm ready’ – to face and
combat the next pathogenic pandemic threat.

Public health relevance
Project Narrative: The BSL3 facilities within the Rocky Mountain Regional Biocontainment Laboratory (RMRBL) at Colorado State University have been responsive to the national RBL mission since 2008, including research and training directed in response to the COVID and MPox pandemics, as well as research and training in other diseases, like Tuberculosis. The RMRBL BSL3 suites are in high demand, and require dedicated management, facilities maintenance, operational support, education and engagement in biosafety and biosecurity practices, and upkeep of relevant scientific technologies to support the studies being performed within this specialized facility. In this application, we address the needs of the RMRBL BSL3 laboratories with 3 Cores to ensure that these facilities are always resourced to face and combat pathogenic pandemic threats; Core 1 is dedicated to improved management, maintenance, and operations, while Core 2 is dedicated to biosafety and biosecurity practices, and finally Core 3 exploits our collective research talents to develop a biocontainment research resource core for pathogen characterization.